A Picture is Worth 1000 Calories: The Neuroimaging of Obesity

DESCRIPTION (provided by applicant): Obesity-associated disease is the fifth leading cause of death worldwide. Obesity is a major risk factor for the development of diabetes, cardiovascular disease, cancer and osteoarthritis. A growing body of animal and human studies implicates deregulation of central dopamine circuits in excessive feeding behavior in obesity. Neuroimaging studies of obese individuals reveal a BMI-dependent decrease in striatal dopamine receptor levels. Interestingly, insulin enhances the surface expression of the dopamine transporter (DAT) while inhibiting that of the nor epinephrine transporter (NET). Together these transporters tune extracellular dopamine levels in the striatum and cortex respectively, areas critically involved in reward, habits, and cognitive control. This suggests tha impaired central insulin signaling, such as has been observed in animals placed on an obesogenic diet could, by blunting striatal, and enhancing cortical dopamine clearance, result in functional impairments in systems mediating food acquisition and overconsumption. In this study, obese individuals with mild impaired insulin signaling, randomized to receive insulin or placebo, will undergo longitudinal nuclear and functional imaging to examine insulin's ability to normalize deregulated striatal and cortical dopamine neurotransmission in obesity. Further, the interaction between dopamine neurotransmission and the effects of insulin specifically on prefrontal cortical function of inhibitory control will be examined. The overarching aim of this study is to assess whether the resetting of central insulin tone will normalize the opposing cortical and striatal dopamine deregulation sub serving the feeding behavior that progressively leads to obesity. This applicant-designed project exploits and expands upon a larger ongoing investigator-initiated patient-oriented clinical study, providing the applicant the opportunity to engage in directly translational research spanning the fields of neuroscience, endocrinology, and biomedical imaging. The proposed research program provides mentorship and training in all of these areas from leading physician scientists and researchers, neuroscience and neuroimaging coursework, and renowned institutional resources for both biomedical imaging and diabetes research. The training plan integrates the core principles of medical and scientific knowledge surrounding the path physiology of neuroendocrine dysfunction in the clinical research setting with the aim of directly translating animal and human research. The training plan emphasizes the acquisition and development of skills required for advanced neuroimaging research, including didactic and extracurricular training in functional and molecular neuroimaging. The finding of whether exogenous insulin modulates dopamine neurotransmission and behavior in a way that is beneficial will ultimately inform the current treatment and management of the global obesity epidemic.

Public health relevance
PUBLIC HEALTH RELEVANCE: The obesity epidemic places over 1.5 billion people worldwide at risk for multiple chronic illnesses, including diabetes, cardiovascular disease, osteoarthritis, and cancer. This patient-oriented, translational research project unites molecular and functional neuroimaging to examine the role of obesity-associated impairment in insulin signaling on brain function, and will provide evidence for how optimizing pharmacologic management of obesity can prevent continued weight gain and obesity associated disease. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Feeding behavior is regulated by complex interactions of central brain circuits with peripheral (blood) signals of energy status and external environmental cues. Dysregulation of this complex neural circuitry can lead to excessive food intake and obesity. Recent functional and molecular neuroimaging studies suggest that dopamine circuits involved in reward, habitual behaviors, and executive function are disrupted in overweight and obese individuals, which may in part underlie the pathological intake of food in excess of energy availability. Human PET imaging studies reveal BMI-dependent decreases in striatal dopamine receptor availability, suggesting a "hypodopaminergic reward deficiency" whereby obese individuals overeat to compensate for a hypofunctioning reward circuitry. However, functional MR studies demonstrate hyperactivation of frontocortical and striatal networks in obese individuals that correlate positively with BMI. These seemingly opposing results are linked by recent animal studies demonstrating that dopamine neurotransmission is under the regulatory influence of insulin. Indeed, insulin promotes the intracellular trafficking and surface expression of the dopamine transporter (DAT), responsible for extracellular dopamine in the striatum, while inhibiting that of the norepinephrine transporter (NET), which regulates extracellular dopamine in cortex. Thus, impaired dopamine signaling in the striatum leads to a synaptic hyperdopaminergia with allostatic downregulation of the dopamine D2 receptor (D2R), but a cortical hypodopaminergia. To date, there have been no studies bridging these molecular findings with human imaging data. In the current proposal, we seek to show that the resetting of central insulin tone will normalize the opposing cortical and striatal dopamine dysregulation subserving the feeding behavior leading to obesity. To meet these goals, we propose two aims: Aim 1. To determine insulin's ability to normalize blunted striatal dopamine neurotransmission in obesity The BMI-dependent decreases in striatal D2R and DAT levels present in obesity normalize with weight loss, and insulin regulation of DAT may facilitate this process. Our goal is to examine the effects of exogenous insulin on dorsal and ventral striatal D2R and DAT levels in obese, weight neutral individuals. Participants will be randomized to an insulin or control arm upon entry to the study and will maintain their body weight for 6 weeks. Participants in each study arm will be randomized to sub-arms to receive the D2R ligand 18F-Fallypride or the DAT ligand 18F-FECNT, with PET radioimaging occurring at the initial and 6-week follow-up visit. Regional 18F-Fallypride and 18F-FECNT non-displaceable binding potentials (BPND) will be calculated for each visit. It is our expectation that, in the absence of weight loss, insulin itself will facilitate measurable increases in striatal D2R and DAT. Aim 2. To characterize the interaction between the molecular and behavioral effects of insulin on prefrontal cortical networks in obesity The prefrontal cortex controls 'top-down' regulation of subcortical, habitual, behavior in part through dopamine's activation of GABAergic inhibitory interneurons, and, as NET trafficking to the plasma membrane is increased in obesity, blunting of dopaminergic disinhibition may underlie the inability to control feeding behavior. Our goal is to examine insulin regulation of dopamine neurotransmission in the prefrontal cortex using the BPND maps generated from the 18F-Fallypride PET imaging, and to relate observable molecular alterations to prefrontal cortical function. Each participant will complete a stop signal task to measure response inhibition. We expect that as insulin restores prefrontal dopaminergic disinhibition, blood-oxygen-level dependent (BOLD) activity in the prefrontal cortex, indicating greater response inhibition, will increase. With these aims as our framework, our goal is to understand how, in the setting of the mild insulin resistance associated with obesity, exogenous insulin modulates dopamine neurotransmission in a way that is beneficial. Given that obesity and insulin resistance represent a global public health problem, and are risk factors for the development of chronic disease, such research would be immediately translational to treatment of the obesity epidemic.